MATERNAL INFLUENCE ON DEVELOPING 24-HOUR PERIODICITY

This proposal focuses on three forms of light perception by the mammalian fetus: maternal-fetal communication of circadian phase, direct perception of light in utero by the fetus, and maternal-fetal communication of daylength. Maternal-fetal communication of circadian phase will be studied in rats. Deoxyglucose and vasopressin mRNA autoradiography are used to monitor the circadian oscillations of a biological clock in the fetal suprachiasmatic nuclei (SCN), while pineal N-acetyltransferase activity and drinking behavior are used to monitor the developing circadian system during the postnatal period. Studies will focus on the mechanism of maternal-fetal coordination, with emphasis on the food ingestion rhythm as the maternal signal. The physiological significance of this prenatal communication will be examined by addressing the potential role of the fetal SCN in the circadian-gated initiation of birth and determining whether the developing circadian system functions normally in the absence of the prenatal maternal signal. The possibility of the direct perception of light in utero by the fetus will be studied in rodents with precocious offspring. The potential for direct light-induced activation of metabolic activity in the fetal SCN of guinea pigs will be examined; deoxyglucose autoradiography will be used to monitor the metabolic activity of the fetal nuclei. Postnatal behavior in spiny mice will be used as a means of examining prenatal influences (such as direct entrainment by light) on developing circadian phase. Maternal-fetal communication of daylength will be studied in Djungarian hamsters. Testicular weight will be used to study the influence of prenatal photoperiod on postnatal reproductive development. The role of maternal melatonin in the prenatal communication will be further defined. The involvement of maternal melatonin in phase communication in this photoperiod communication will also be examined. Finally, the physiological significance of phase communication for proper postnatal photoperiodic responses will be investigated. The results of these studies will advance our knowledge of the mechanisms and physiological significance of light perception by the mammalian fetus.